Intergenerational and Cultural Drivers of Depressive Symptoms in Hispanic Sexual Minority Youth

ABSTRACT
Adolescent mental health has been declared a national emergency, and disparities exist among sexual and
ethnic minority adolescent sub-groups. Specifically, Hispanic sexual minority youth (HSMY) bear a
disproportionate burden of depressive symptoms compared to their non-Hispanic white, heterosexual
counterparts. While this health disparity is partly attributed to the marginalization experienced by HSMY on behalf
of their intersecting minority identities, little research has been done to understand the mechanisms through
which other culturally-relevant, multi-level factors may also contribute to the high rates of depressive symptoms
in this population. In an effort to highlight points of intervention to confront these disparities and the ongoing
national emergency, this proposal will explore how multi-level factors, such as the intergenerational effect of
caregiver childhood trauma (operationalized as adverse childhood experiences[ACEs]), caregiver-HSMY
acculturation differences, and caregiver-HSMY communication quality, may affect HSMY depressive symptoms.
Guided by ecodevelopmental theory, I will harmonize existing longitudinal datasets consisting of caregiver-HSMY
dyads and collect rich qualitative data from HSMY to accomplish two specific aims: 1) Examine whether a) an
intergenerational direct effect of caregiver ACEs on HSMY depressive symptoms is b) mediated by caregiver-
HSMY communication quality and c) if this indirect pathway is moderated by a discrepancy between caregiver
and HSMY Americanism (a subtype of acculturation); and 2) use ecodevelopmental theory to investigate
potential drivers of HSMY depressive symptoms. The accompanying training plan will provide the foundation
for me to a) advance my knowledge in intergenerational effects of childhood trauma and its implications for
intervention development in Hispanic youth, b) develop advanced skills in longitudinal analyses and data
harmonization; c) develop advanced skills in qualitative analysis, and d) enhance my skills in interdisciplinary
team science and professional development. I have a strong and highly successful mentorship team dedicated
to my growth and development to guide me throughout this award. Together, the research and training proposal
will support my development as an independent nurse scientist in the area of HSMY mental health. This NRSA
F31 proposal aligns with the NINR’s Strategic Plan with its focus on understanding drivers of mental health
disparities in adolescents and families with shared characteristics. The proposed study will generate important
knowledge related to the intergenerational effect of caregiver childhood trauma on HSMY mental health and
examine a mechanism (i.e., caregiver-HSMY communication quality) through which this effect may exist. The
findings stand to inform whether culturally-tailored, family-based interventions aimed at advancing HSMY mental
health equity should target caregiver-HSMY communication quality and incorporate trauma-informed care.

Public health relevance
PROJECT NARRATIVE The proposed study will explore the intergenerational effect of Hispanic caregivers’ childhood trauma on their sexual minority youth’s depressive symptoms and the mechanisms through which this relationship may exist, such as communication quality and acculturation discrepancies between caregivers and their adolescents. Understanding these relationships offers opportunities to inform family-based interventions focused on preventing and reducing depressive symptoms in a population experiencing mental health disparities. This award will support my development toward becoming an independent nurse scientist dedicated to improving mental health equity through family-based interventions for Hispanic sexual minority youth.